Elucidating mechanistic connections between guidance signaling, microtubule regulation, and growth cone steering

Project Summary/Abstract
This proposal focuses on the fundamental question of how neuronal growth cones are guided to their targets. It
has long been established that growth cone navigation depends on regulated changes in both F-actin and
microtubule (MT) dynamics in response to guidance cues. However, the mechanisms by which these cues
bring about specific changes in growth cone MT dynamics are unresolved. This proposal takes aim at that
void, by investigating the function of the MT polymerase and ‘plus-end tracking protein’ (+TIP), XMAP215,
along with its regulatory mechanisms. Our recently published data identified an ability for XMAP215 to bind
directly to F-actin and promote MT extension into the growth cone. This is complemented by unpublished data
that kinase signaling modulates the ability of XMAP215 to promote MT-F-actin interaction. Our data support a
model in which XMAP215 mediates MT-F-actin coupling through structural domains distinct from those
regulating MT polymerization, and that XMAP215 converts signals from upstream guidance cues into changes
in cytoskeletal coordination, ultimately directing growth cone motility. We will test this in Xenopus laevis using
an array of complementary cell-based and biochemical approaches. The specific aims are: Aim 1 – Identify the
mechanism by which XMAP215 interacts with F-actin in vitro. We will determine the specific domain of
XMAP215 that binds to F-actin as well as identify how the binding is regulated. We will produce a variety of
deletion and phosphomutant XMAP215 proteins, and we will use a series of biochemical techniques including
F-actin/MT co-sedimentation binding assays, multi-wavelength TIRF microscopy with in vitro cytoskeletal
reconstitution assays, mass spectrometry, as well as EM experiments, to dissect the mechanism by which
XMAP215 binds to F-actin in vitro. Aim 2 - Determine how regulation of XMAP215 interaction with F-actin
modulates cytoskeletal dynamics and growth cone behaviors in cultured neurons. We will use structured
illumination microscopy (SIM), spinning disk confocal microscopy, and quantitative imaging analysis of +TIP
dynamics in cultured neurons, after expressing various XMAP215 mutants, to uncover new mechanistic
insights into how XMAP215 regulates MT-F-actin interactions in growth cones during axon outgrowth. Aim 3 -
Define how XMAP215 interaction with F-actin contributes to accurate axon guidance. We have discovered that
normal XMAP215 levels are required for cultured growth cones to be repelled from the axon guidance cue,
Slit2. We will use a combination of ex vivo and in vivo axon guidance assays to determine how growth cone
steering is impacted by the ability of XMAP215 to facilitate MT-F-actin interactions. The results of these Aims
will reveal the direct links between guidance cue signaling, kinase regulation of the only well-characterized MT
polymerase (XMAP215), and cytoskeletal coordination, within the context of growth cone steering. As such,
this proposed work has the potential to bring a long-needed mechanistic understanding to the question of how
extracellular cues govern cytoskeletal dynamics to effectively steer growth cones during neurodevelopment.

Public health relevance
Project Narrative/Public Health Relevance Statement Proper neural connections are essential for normal nervous system function. Abnormalities in neural connectivity are associated with a multitude of neurodevelopmental and mental health disorders, including autism and schizophrenia. Determining the mechanisms by which cytoskeletal elements inside the growth cone are coordinated to drive the morphological responses of the growth cone (advance, retraction, and turning) may eventually lead to understanding the basis of neuropsychiatric disorders and may contribute to designing prevention and/or treatment strategies in the future.